Liquid biopsy approaches to inform neuroblastoma prognosis and disease monitoring

Abstract
Fewer than half of all children with high-risk neuroblastoma become long-term survivors. Currently, it is not
possible to predict if a child will be cured with standard therapy or is destined to relapse. Furthermore, standard
clinical evaluations lack sensitivity to detect minimal residual disease (MRD) that ultimately leads to recurrence.
Thus, there is a critical challenge and an unmet need to develop new precision biomarkers to identify patients
who will ultimately have a poor response to the high-intensity therapy and may benefit from alternate approaches.
We will develop new biomarkers to guide treatment decisions using cell-free DNA (cfDNA) and a novel,
epigenetic-based methodology that will identify underlying biology driving aggressive neuroblastoma. In many
cancer types, analysis of cfDNA isolated from peripheral blood has shown promise, revealing biomarkers for
diagnosis, prognostication, and tumor surveillance. Cytosines in DNA can either be unmodified, methylated (5-
methylcytosine, 5mC), or contain an oxidized form of 5mC, 5-hydroxymethylcytosine (5hmC). Unlike 5mC,
elevated 5hmC deposition across a gene body marks active transcription. In this proposal, we will use nano-
hmC-seal, a whole-genome methodology for analyzing 5hmC modifications in cfDNA. Recently, we evaluated
5hmC in cfDNA collected serially from children with neuroblastoma and demonstrated that 5hmC profiles
correlated with disease burden and patient outcome. Importantly, we also found a cfDNA 5hmC derived
biomarker can distinguish patients with superior response to treatment from those at high risk for relapse. 5hmC
profiles from cfDNA compared to diagnostic high-risk primary tumors demonstrated cfDNA is derived from
clinically aggressive, malignant cells with activation of networks common in relapsed tumors. To prospectively
determine the prognostic strength of 5hmC-based cfDNA biomarkers, we will use nano-hmC-seal to generate
5hmC profiles from clinically annotated serial blood samples (liquid biopsies) collected from 400 patients enrolled
on the ongoing Children’s Oncology Group High-Risk Neuroblastoma Phase III study (ANBL1531,
NCT03126916). We hypothesize that cfDNA 5hmC profiles from children with neuroblastoma will serve as
superior biomarkers for response and survival compared to current clinical methods and will reveal transcriptional
networks driving relapse. The specific aims are: 1) Evolve and validate biomarkers of poor response at diagnosis;
2) Prospectively identify minimal residual disease (MRD) and predict relapse from serial cfDNA 5hmC profiles;
3) Experimentally confirm candidate networks enriched in cfDNA at relapse. The success of this proposal will
lead to: 1) unprecedented diagnostic biomarkers to improve therapeutic decisions; 2) early detection and
interventions for patients with relapse causing MRD; 3) identification of epigenetic mechanisms which drive
relapse. This work will have a transformative impact by to identifying patients who benefit from early introduction
of alternate therapy, improving outcomes for those with aggressive disease.

Public health relevance
Project Narrative Fewer than half of all children with high-risk neuroblastoma become long-term survivors. The goal of this project is to develop biomarkers to improve risk stratification at diagnosis, biomarkers of minimal residual disease for early therapy intervention, and the identification of gene networks which drive high-risk neuroblastoma. This work will have a transformative impact by identifying new ways to diagnose and monitor neuroblastoma using liquid biopsies, potentially enabling early introduction of novel therapeutics.